Effect of Borrelia burgdorferi-SIRPalpha Interaction on the Immune Response

Innate immunity is the first line of defense against pathogens, and it is critically reliant on the efficient
elimination of the invading agents by phagocytosis. Phagosomal digestion enables microbial killing, antigen
presentation to activate adaptive immunity and establish immune memory, and the activation of appropriate
inflammatory responses. It has recently become clear that the tick-borne pathogen B. burgdorferi (Bb), an
agent of Lyme disease, can evade phagocytosis by macrophages through a novel mechanism. Molecular
mimicry of the “don’t eat me” signals that block phagocytosis of host cells allows Bb to engage SIRPα (signal
regulatory protein alpha) on the surface of macrophages. CD47 is known to be upregulated by cancer cells and
virally infected cells, thus allowing them to escape phagocytic clearance. More recently, it’s become clear that
this innate immune checkpoint is hijacked by the Bb virulence protein, P66, that functionally mimics CD47. P66
is encoded by all Borrelia species, and binds to the phagocyte receptor SIRPα with high affinity, reducing Bb
phagocytosis. Evasion of phagocytic clearance is likely an essential component of Bb’s ability to cause
persistent infection, and likely to be critical for both maintenance of the enzootic cycle and the debilitating
disease observed in many patients. Genetic deletion of p66 increases macrophage phagocytosis of Bb in
addition to blocking P66’s well-established porin and integrin-binding functions. Thus, Bb mutants that do not
produce P66 (p66::kana; termed Dp66 here) are not infectious in mice, as they are detectable by quantitative
PCR (qPCR) or culture only at the site of inoculation ~ 1-2 days post-injection, while complementation of p66
to its endogenous genetic locus (p66cc) reconstitutes disseminated infection longer than 2 days in duration
(hereafter referred to as “infectivity”) in mice. Phagocytosis is important for pathogen clearance, antigen
presentation, adaptive immunity, and appropriate inflammation, thus we will determine how engagement of
SIRPa by Bb P66 subverts the immune response. Our hypothesis is that P66-SIRPa interaction
diminishes the development of effective innate and adaptive immune responses to Bb in mice. We will
test this hypothesis using complementary approaches targeting both bacterial P66 and host SIRPa,
leveraging both microbiological and immunologic approaches to illuminate this novel mechanism of immune
evasion. Using commercially available mice, we will quantify Bb loads and dissemination kinetics, and murine
antibody and cellular responses to the bacteria over six infection times. Since bacterial targeting of SIRPa is,
to date, novel, we expect this work to shed light on the fundamental biology of Bb and its host-dependent life
cycle, particularly the novel role of a bacterial “don’t eat me” surface protein and how it affects the immune
response that does not clear the infection in immunocompetent hosts.

Public health relevance
Project Narrative Borrelia burgdorferi, an agent of Lyme disease, binds to a receptor on immune cells from humans and mice called SIRPa. This binding blocks the uptake and digestion of bacteria by immune cells, a step that is necessary for both controlling the infection and for developing long-lasting immunity. The goal of this project is to determine how B. burgdorferi uses this mechanism to manipulate the immune system through use of genetically altered mice and bacteria.